Clinical Research Imaging Core

PROJECT SUMMARY / ABSTRACT
The mission of the Clinical Research Imaging Core (CRIC) is to advance cancer research at the University
of Wisconsin Carbone Cancer Center (UWCCC) by supporting the accurate and efficient use of image-
based outcome measures in oncology clinical research. CRIC does this by partnering with the Department
of Radiology’s 1) Medical Imaging Research Support (MIRS), the imaging research administrative and
support arm of Radiology, 2) Radius Core Lab, the dedicated image analysis lab within MIRS, and 3)
Radiopharmaceutical Production Facility (RPF). CRIC provides UWCCC members and Disease-Oriented
Teams (DOTs) with a dedicated clinical research imaging support hub that is integrated with their clinical
studies and aligned with their research interests and initiatives to successfully incorporate conventional and
novel clinical oncology imaging. Aim 1: CRIC provides UWCCC clinical trial protocol imaging and
radiopharmaceutical feasibility review to identify and navigate any obstacles to study activation and
clinical trial workflow implementation. This includes addressing feasibility, technical, and regulatory
considerations for standard-of-care and investigational imaging techniques needed for study activation, and
determining appropriate tumor response assessment imaging methodologies. Aim 2: CRIC partners with
MIRS for coordination of proper UWCCC cancer-specific clinical research integration and imaging
resource use, and with RPF for PET imaging needs. CRIC serves as the liaison for communication and
integration of UWCCC clinical trial research needs with MIRS imaging workflows, infrastructure, and
personnel. CRIC ensures UWCCC members and DOTs access to research scanner use and imaging
support, including enabling application of novel investigational imaging methods. CRIC coordinates with the
RPF for inclusion of clinical or investigational PET imaging agents in UWCCC clinical trials. Aim 3: CRIC
partners with MIRS Radius Core Lab to provide imaging tumor response assessment services for
accurate and efficient image-based outcome measures in UWCCC clinical trials. This partnership
between CRIC and the Radius Core Lab brings expert image analysis and review by experienced radiology
faculty to UWCCC clinical trials with detailed standardized reports, using standard CT anatomic tumor
response assessments and those that are PET/CT based. Aim 4: CRIC will facilitate the development
and expansion of emerging UWCCC theranostic clinical trials. Theranostics involves the use of
radiopharmaceuticals for cancer diagnostics and therapy. CRIC will play a vital role in expanding
theranostics trials at UWCCC through a developing Theranostic DOT and dosimetry service. Impact: CRIC
in partnership with Radiology’s MIRS, MIRS Radius Core Lab, and RPF ensures efficient and accurate
application of standard-of-care and innovative novel imaging methods, along with imaging expertise, to
advance imaging-based metrics and support high-impact clinical research at UWCCC.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.